Atmospheric transformation of harmful cyanobacterial algae and novel mechanisms of pulmonary toxicity

PROJECT SUMMARY
HABs occur when colonies of algae grow out of control and negatively impact ecosystems. These blooms can
produce toxins that can have detrimental effects on animals and can also make humans sick. Blooms caused
by cyanobacteria (CB) in freshwater systems are prevalent across the U.S. and are expected in increase with
rising water temperatures and more frequent and severe weather events. CB produce toxins, including
microcystin-LR (MC-LR) and cylindrospermopsin (CYL), that are associated with acute liver and kidney toxicity
after exposure through ingestion of contaminated food or water. Inhalation exposures are increasingly
recognized as an important exposure route yet few studies have examined whether inhaled HAB aerosols have
subacute health implications. Compared to water, atmospheric transformation of HAB components occur rapidly
and tend to occur faster in air than in water. Toxins can be complexed with algal organic matter which may also
aid in photooxidation. Uncovering the atmospheric aging of HAB is critical to defining inhalation exposures and
associated health effects. Acute respiratory symptoms (i.e., coughing) have been documented in people near
CB blooms but no studies have investigated subacute effects. Data from animal and cell studies support that
classic modes of toxicity (i.e. hepatotoxicity) that rely on special transporters are not present in the lung but noted
changes in immune responses have been observed. This lack of knowledge of CB aerosols and their
mechanisms of action once inhaled are the basis for the research addressed in the current proposal. To address
these knowledge gaps, our innovative approach will utilize a environmental chamber to produce and characterize
atmospherically transformed aerosols of CB that will be applied directly to highly differentiated cultures of human
primary lung cell cultures grown on an air-liquid interface supports. We will also perform novel mechanistic
investigations by probing the ability of HAB-exposed lung cells to modulate critical immune cells (dendritic cells)
through the production of extracellular vesicles. We will test the overall hypothesis that transformed aerosols
of CB that produce the greatest extracellular ROS will trigger robust ROS and immune cellular responses
evidenced by changes in epithelial cell genes, ROS production and secretion of EVs. Furthermore these
EVs will modulate dendritic cells by altering their transcriptome and pushing them to a maturation state.
To test this hypothesis we propose two specific aims: (1) characterization of fresh and aged algal aerosols and
toxins, and (2) evaluate toxicity of aged algal aerosols and toxins to highly differentiated human lung epithelial
cells and test whether released EVs alter the maturation and transcriptional profiles of dendritic cells. This work
is both significant and innovative as successful completion will generate first-time toxicity profiles for airborne
HABs in cell models that more closely mimic in vivo airways. In addition, data produced will provide a unique
view on newly identified mechanisms of action of CB in the lung which support inhalation and pulmonary health
as a risk for exposed populations.

Public health relevance
PROJECT NARRATIVE Harmful algal blooms (HABs) are most commonly known to make animals and people sick through contaminated food and water. We now know that HABs can also can become aerosolized and inhaled but the associated health effects are not well understood. Defining a role for HAB aerosols in the protection of human health by advancing our understanding of inhalation exposures and novel health outcomes is critical to inform management programs and health risk.